Improving the prediction of bronchopulmonary dysplasia by identifying kidney-based risk factors

Approximately 50,000 infants are born less than 28 weeks’ gestation in the United States each year, and the
development of severe bronchopulmonary dysplasia (BPD) in these infants is common. However, difficulties
with early identification of at-risk infants and incomplete knowledge of modifiable risk factors have hampered
improvements in BPD care. Acute kidney injury (AKI) and fluid overload are emerging risk factors for severe
BPD in premature infants. A more complete understanding of how AKI and fluid overload in infants impacts the
development of BPD could lead to better-targeted interventions in the early neonatal period as AKI and fluid
overload are both preventable and treatable conditions. My long-term career goal is to develop a portfolio of
research focusing on the relationship between lung and kidney disease in premature infants and decreasing
the incidence of BPD in premature infants by identifying and mitigating kidney-based risk factors. This K23
proposal summarizes a 5-year program of mentored professional development tied to a research project to
establish critical kidney-based candidates for early detection of severe BPD in premature infants and develop a
clinical prediction model to identify premature infants at risk for severe BPD. My central hypothesis is that
acute kidney injury (AKI) and fluid overload contribute to severe BPD development and are linked by
angiogenesis. Specific aims for the K23 are to: (1) Develop a clinical prediction model that uses markers of
kidney disease to estimate severe BPD risk in premature infants, and (2) Identify longitudinal patterns of
angiogenesis biomarkers in premature infants that predict BPD. Aim 1 will test the hypothesis that a clinical
prediction model which incorporates both AKI and fluid overload will more accurately identify BPD in premature
infants than an existing model. Aim 2 will test the hypothesis that premature infants with AKI and subsequent
severe BPD will have altered patterns of angiogenesis during their neonatal hospitalization. Through my career
development plan and guidance from my mentors, I will develop expertise in a) bronchopulmonary dysplasia
and angiogenesis, b) machine learning and health informatics, and c) clinical trial design and biostatistical
principles. Together, the research and educational aims of this proposal will provide me with the necessary
groundwork to compete for additional funding as an independent investigator. Specifically, I will seek R01 grant
funding from the NHLBI in year 4 of my K23 award to develop individualized fluid management and AKI
detection/treatment protocols for testing in a clinical trial. I will also apply for an R03 in year 3 to further
augmented the developed clinical prediction models with biomarkers. Overall, my proposed line of research is
the first step in a career focused on the detection, monitoring and treatment of kidney-based risk factors for
BPD in premature infants. I will accomplish this work under the mentorship of a multidisciplinary team of faculty
with expertise in health services research, clinical trials, machine learning, bronchopulmonary dysplasia, and
kidney disease.

Public health relevance
Project Narrative In the US 50,000 infants each year are born less than 28 weeks of gestation, and severe bronchopulmonary dysplasia (BPD) poses a tremendous health and economic burden in these infants. This foundational work seeks to improve severe BPD prediction by a) focusing on kidney-based risk factors of acute kidney injury and fluid overload and b) identifying critical biomarker candidates. Improving severe BPD predication with kidney- based risk factors and biomarkers will facilitate individualized fluid management and improved AKI detection and treatment, decreasing the diagnosis and severity of BPD in prematurely born infants.